Pilot-Feasibility

PILOT STUDY CORE – PROJECT SUMMARY/ABSTRACT
The Batten Disease Clinical Research Consortium (BDCRC) Pilot Study Core will be a cornerstone of the
Consortium's overarching mission to advance knowledge and provide pragmatic research approaches to
advance early diagnosis, management, and treatment; to improve clinical trial readiness; and to address other
key unmet areas of need for the Batten disease community. Through a highly collaborative, patient-centric
approach, the Pilot Study Core will solicit, rigorously evaluate, and fund high-quality, innovative translational and
clinical pilot studies. Studies will address one or more of the Top Research Priorities identified through a recent
survey of Batten disease community stakeholders, developed using an established Research Priority Setting
Partnership methodology. Leveraging existing collaborations, resources, and infrastructure of the BDCRC, along
with the Batten Disease Support, Research, and Advocacy Foundation, the Batten Disease Global Research
Initiative, and other strategic partners, the Pilot Study Core will solicit proposals from a wide range of researchers,
including early career investigators and established investigators from outside the Batten disease field. The Pilot
Core Committee will draw upon its diverse professional expertise to employ a systematic, rigorous, NIH-based
process for evaluating and selecting at least one project per year based on eligibility, relative merit, feasibility,
and alignment with stakeholders' Top Research Priorities. The Core will facilitate the successful execution and
completion of these pilot studies though provision of practical support and mentorship throughout the entire
lifecycle of the project: from commencement of the Award (Phase I), through the active research period (Phase
II), project completion (Phase III), and the post-research phase (Phase IV). By providing end-to-end support for
promising, innovative proof-of-concept studies, the Pilot Study Governance Core will be a central component of
the BDCRC and its mission to address unmet research needs and to meaningfully improve clinical outcomes for
those living with Batten disease.